Neutrophil Responses Drive Diseases of the Alveolar Space

PROJECT SUMMARY/ABSTRACT – PROJECT 1
Lower respiratory tract infection (pneumonia) causes almost 80% of deaths due to infection. For many otherwise
fatal lung diseases, lung transplantation is the only curative option yet carries a dismal 5-year survival of 50%.
Primary graft dysfunction following lung transplantation is responsible for the bulk of the early mortality following
lung transplantation and is the dominant risk factor for chronic lung allograft dysfunction, the major barrier to long
term survival in lung transplant recipients. We and others determined that a profound neutrophilic alveolitis is
central to both pneumonia and PGD, yet mechanisms underlying the pathobiology of neutrophilic lung injury in
these important diseases remain unclear. At Northwestern, we have created robust research programs engaged
in high-volume, serial bronchoalveolar lavage fluid, lung tissue, and blood sample collection from patients with
pneumonia as part of routine clinical care as well as from donor lungs throughout the course of lung
transplantation. Hence, we are well-positioned to test mechanistic questions about the activation, migration, and
function of lung neutrophils in well-phenotyped patients with neutrophilic alveolitis. Historically, neutrophils have
been viewed as a homogenous, single-function population; however, our preliminary data point to substantial
heterogeneity in lung and blood neutrophils. For example, we identified heterogeneity in expression of the
integrin CD11b, which we found serves as a negative regulator of inflammatory signaling. We also observed in
preliminary data that type I and II interferons (IFNs) have different expression levels in the circulation versus in
the alveolar space and that lung epithelial and endothelial cells are sources of the key neutrophil cytokine CSF3.
Hence, we hypothesize that CD11b/TLR/MYD88/NFκB signaling and systemic and tissue-derived signals
(CSF3 and type I and II IFN) regulate neutrophil activation, migration, and function in patients with severe
pneumonia and PGD. To test our hypothesis in humans, we will perform systematic sampling and
multidimensional assessment using single-cell sequencing and spatial profiling of neutrophils in the circulation
and alveolar compartments of hundreds of patients with severe pneumonia and PGD. We will integrate these
molecular datasets with ex vivo functional assays and deep clinical phenotypes. In Aim 1, we will determine
whether CD11b/TLR/MYD88/NFκB signaling and type I and II IFN control neutrophil activation, migration, and
function in patients with severe pneumonia and PGD. In Aim 2, we will determine whether CSF3 generated
within the alveolus determines neutrophil maturation, activation, migration, and function and whether arginase-
1 and BAFF link persistent neutrophilia to adaptive immunity in patients with pneumonia and PGD. In both Aims,
we will use cutting-edge computational strategies to test whether these pathways are associated with disease
etiology, steroid responsiveness, age, and mortality in patients with severe pneumonia and PGD. We will address
critical knowledge gaps by investigating neutrophil activation, migration, and function in patients with severe
pneumonia and PGD with the goal of therapeutic targets for these devastating diseases.

Public health relevance
NARRATIVE A project narrative is not required for this component per instructions stated on the Funding Opportunity Announcement RFA-AI-22-069, “Project Narrative: Do not complete.”